PDE2a inhibition as a therapeutic target for the chronic effects of repetitive mild TBI

Among surviving soldiers wounded in Iraq and Afghanistan, TBI accounts for a larger proportion of
casualties (> 22%) than in other recent US wars, and accounts for a large proportion of the acute and
long-term combat casualty care burden. The military loses thousands of man-years in experience, each
year due to the effects of TBI in soldiers, including those prematurely returned to active duty as well as
soldiers who cannot return to service and add to the already heavy burden on the VA healthcare system.
Many young adults never regain premorbid skills or responsibilities after TBI despite intensive and
comprehensive rehabilitation efforts on their behalf. The sequelae of TBI are a mixture of cognitive
psychomotor and emotional (psychiatric) signs and symptoms, and the emotional and psychological
burden on patients and caregivers can be enormous. Repetitive mild TBI (r-mTBI) is one of the most
devastating outcomes of the recent conflicts. The diversity of etiology of human TBI poses problems for
identification of valid therapeutic targets and the relevance of preclinical models is key.
There is a clear need for improved and increased modeling of r-mTBI in the laboratory, to enable
the dissection and evaluation of TBI-dependent molecular responses and identification of better
approaches to mitigate the negative outcomes. We have developed several different mouse models of
repetitive mild TBI, with different neurobehavioral, neuropathological and biochemical outcomes. They
recapitulate features of human TBI and our clinical collaborators consider them to be of relevance as
translational platforms. We have pioneered assessment at chronic timepoints, and delayed treatment
approaches in order to better model the human situation. Our overarching hypothesis is that treatments
showing efficacy with late treatment initiation in multiple different r-mTBI models will have most potential in
clinical translation to address the vast heterogeneity inherent in the human r-mTBI patient population.
We have recently completed a VA RR&D funded project in which we demonstrated improved
neurobehavioral and neuropathological outcomes in two different mouse models of r-mTBI following
delayed treatment with the anti-inflammatory compound anatabine. We also demonstrated positive
outcomes in one of these models with immediate treatment with the putative anti-Alzheimer therapeutic
Nilvadipine. Proteomic analysis on the brains of these mice identified phosphodiesterase 2a (PDE2a) as
a critical molecule in r-mTBI pathogenesis, which was significantly upregulated in response to r-mTBI, as
were PDE2a-containing molecular signaling pathways such as cAMP-mediated signaling and Protein
Kinase A signaling. cAMP and cGMP mechanisms have both been identified as potential targets for
Alzheimer’s Disease and related disorders, but have not previously been specifically addressed in relation
to r-mTBI. Treatment with either anatabine or nilvadipine resulted in decreased expression of r-mTBI-
induced PDE2a and/or mitigation of the r-mTBI-induced effects on the PDE2a signaling pathways. In a
pilot study conducted since the original submission we have now demonstrated that PDE2a inhibition
mitigates the subacute behavioral, biochemical and pathological consequences of r-mTBI.
Thus, in this new project, we will focus on PDE2a inhibition to treat the chronic effects of r-mTBI.
We will use two different mouse models – a 5 hit paradigm over 9 days (5r-mTBI) and a 20 hit paradigm
over 28 days (20r-mTBI), all injuries being the same mild TBI administered on the midline of a closed
skull. Using a well-characterized PDE2a inhibitor, we will determine if inhibition of PDE2a mitigates the
chronic neurobehavioral, neuropathological and biochemical consequences of r-mTBI, as well as the most
effective administration paradigms, and through single cell transcriptomic analyses we will identify specific
mechanisms of action for PDE2a which will provide additional potential therapeutic targets.

Public health relevance
This goal of this project is to address the lack of any effective treatment options for patients suffering from repetitive mild TBI (r-mTBI) by validating a novel target identified through our previous RR&D research on proteomic characterization in our well characterized and translationally relevant r-mTBI mouse models. We have developed and characterized different injury paradigms for r-mTBI, each with different timelines and presentations of neurobehavioral and neuropathological outcomes. Used collectively, these models help to address the heterogeneity of human TBI, which has been one of the confounders for clinical trials. Our proteomic and transcriptomic characterizations have identified phosphodiesterase 2a (PDE2a) as a critical regulator of TBI pathobiology in multiple models, and so in this project we plan to validate pharmacologic inhibition of PDE2a with different administration paradigms in chronic studies of r-mTBI outcomes in our models. Successful validation could rapidly translate into human clinical trials for r-mTBI.